Role of the ubiquitin E3 ligase HUWE1 in age-associated nonalcoholic fatty liver disease

Abstract
Nonalcoholic fatty liver disease (NAFLD) is the most common liver pathology worldwide and is estimated to affect
nearly 30% of the population. Rather than a single disorder, NAFLD refers to a spectrum of conditions that are
characterized by excessive fat accumulation in the liver (hepatic steatosis) that occurs independently of
excessive alcohol ingestion. With increased hepatocyte injury and inflammation, hepatic steatosis can progress
to nonalcoholic steatohepatitis (NASH), followed by cirrhosis and fibrosis which lead to increased risk for
developing hepatocellular carcinoma (HCC). Although hepatic steatosis can be reversed in early NAFLD with
weight loss, diet, and exercise, liver damage resulting from inflammation, cirrhosis, and fibrosis observed in
advanced NAFLD is often deemed irreversible. Therefore, there is a critical need to identify molecular
mechanisms contributing to NALFD etiology and progression to identify therapeutic targets before the disease
becomes clinically unmanageable. While several factors are known to contribute to the onset and progression
of NAFLD-related disorders, aging is one of the highest risk factors. However, the mechanism underlying age-
associated NAFLD remain incompletely understood. HUWE1 is a HECT-domain ubiquitin E3 ligase ubiquitously
expressed in normal tissues. HUWE1 ubiquitinates a wide range of cellular substrates, including p53, MYC, and
MCL1. Given the diverse substrates, the in vivo role of HUWE1 in human disease remains elusive. We have
recently identified that HUWE1 is a critical mediator of NAFLD etiology as liver-specific Huwe1 knockout
rendered mice protected against hepatic steatosis induced by age. Our novel data suggest that dysregulation of
hepatic HUWE1 may play an important role in the pathogenesis of age-associated NAFLD. To test this
hypothesis, we will identify the mechanism of how HUWE1 promotes age-associated NAFLD (Aim 1) and identify
the substrate of HUWE1 that prevents the disease in mice (Aim 2). The successful completion of the proposed
study will establish HUWE1 as a key regulator of age-associated NAFLD. This outcome will have a durable
impact in the field since it will uncover a signaling pathway previously unrecognized and provide a rationale for
investigating the mechanism of HUWE1 regulation in aging hepatocytes.

Public health relevance
Project Narrative Nonalcoholic fatty liver disease (NAFLD) is the most prevalent form of liver disease worldwide and is estimated to affect nearly a third of the population. Although its underlying mechanisms remain incompletely understood, aging is known to play a major role in the development of NAFLD. The proposed research will investigate the mechanism of age-associated NAFLD using mouse models. 1